Targeting hepatitis B virus cccDNA during HBV/HIV co-infection

Project summary
Coinfection with HBV and HIV-1 is common, and HIV coinfection can exacerbate progression of viral hepatitis and
accelerate liver disease progression. In fact, endstage liver diseases, including fiboris/cirrhosis and hepatocellular
carcinoma, have become the most common causes of death in people living with HIV (PWH) worldwide. HIV
infection cannot be cured currently but can be efficiently suppressed with highly active or combination anti-retroviral
therapy (HAART or cART). Currently available HBV drugs can suppress viral replication, but only a small subset of
patients are cured by these treatments. Although a prophylactic vaccine is available for HBV, it has no therapeutic
benefit. Consequently, new therapeutic approaches are urgently needed to combat chronic HBV infection,
particularly in the context of HIV coinfection. Here, we will capitalize on several technical and conceptual
breakthroughs from our lab to establish proof-of-concept for interfering with persistent HBV infection virologically.
We have recently made important discoveries that provide a strong foundation for the major direction of this
proposal. The Ploss lab identified key components of the DNA lagging strand synthesis machinery that are
necessary and sufficient for formation of HBV cccDNA, the replication intermediate crucial for viral persistence.
Clinical data from HBV patients indicate that cccDNA turnover occurs relatively rapidly (several months), offering a
possibility of curing HBV with finite therapy by completely blocking cccDNA replenishment. Thus, we aim to
determine whether liver-specific transient genetic disruption of polymerases and other co-factors in vivo can
abrogate HBV infection (Aim 1). Since we recently demonstrated that HBV cccDNA formation is supported in mouse
hepatocytes, we can take advantage of the power of mouse genetics to rigorously test our hypothesis that genetic
distruption of host factors involved in cccDNA formation can abrogate HBV infection. Furthermore, we will extend
our analysis to blocking HBV chronicity in the context of an underlying HIV coinfection (Aim 2). To achieve this
goal, we will take advantage of a novel humanized mouse model co-engrafted with HLA-matched human
hepatocytes and components of a human hematolymphoid system. Our preliminary data demonstrate that such
dually engrafted mice support chronic infections with both HBV and HIV and can mount antigen-specific T cell
responses. This humanized mouse model provides unprecedented opportunities for studying the complex interplay
of HBV/HIV co-infections and will be deployed here to test rigorously whether blocking HBV cccDNA formation can
abrogate HBV persistence.
We will capitalize on our extensive complementary expertises in virology and immunology of HIV-1/HBV (Su),
hepatitis viruses (Ploss) and humanized mouse technology to achieve these exciting aims. Our work will advance
the field of HBV and HIV-1 research by showing that a novel small animal model can be successfully used to
understand HIV/HBV coinfection and immune responses and to model treatments for the associated liver disease.

Public health relevance
Public health narrative Coinfection with HBV and HIV-1 is common, and HIV coinfection can exacerbate progression of viral hepatitis and accelerate liver disease progression. Our proposed work will use a cutting-edge humanized mouse model to test novel approaches for gaining insights into the mechanisms of HBV persistence in the context of HBV/HIV coinfection.